Seizure control by electric field control

Abstract
A seizure is an abnormal neural activity in the brain and the main characteristic of epilepsy. About one-third of
the patients have seizures resistant to anti-epileptic medication and therefore, an alternative treatment is
necessary. Recent studies show that neurons can be recruited and seizures can propagate by a mechanism
known as electric field coupling. Our laboratory has shown that canceling the electric field in the extracellular
space can prevent neural propagation and recruitment. We now propose to develop a novel neurotechnology
that not only can control the propagation of seizures but prevent the seizure from being generated by controlling
the extracellular electric field. With a combined methodology of in-vitro electrophysiology with state-of-the-art
neural imaging, computer modeling and in-vivo preparations in rodents, we will implement the seizure control
system and study its mechanism with four specific aims: 1) Prevent neuronal synchronization in hyperexcitable
neural tissue, 2) Develop a novel technology of extracellular voltage clamp to control seizures in-vivo, 3)
Determine the mechanisms of seizure control by an extracellular voltage clamp system, 4) Determine the role of
the extracellular space in the clamping efficiency. Current electrical responsive control therapy detects a seizure
and then applies stimulation. The proposed neurotechnology will prevent the synchronization between neurons
to stop the generation of seizures before they arise at very low current amplitude thereby providing a novel
therapeutic paradigm for treating epilepsy.

Public health relevance
Narrative: Epilepsy is characterized by recurrent seizures and is frequently resistant to antiepileptic drugs. This new proposal focusses on the design of a novel neurotechnology to control seizures based on the new finding that the neuro electric field plays a crucial role in the generation propagation of seizures electric field coupling.